University of Kentucky Center for Clinical and Translational Science Enterprise Data Center Expansion

PROJECT SUMMARY/ABSTRACT
The University of Kentucky (UK) proposes to significantly advance its secure research data infrastructure
capacity within the Enterprise Data Center (EDC), an integral component of the Kentucky Center for Clinical
and Translational Science (CCTS). The CCTS currently supports more than $34.1 million in annual direct cost
grant funding to support biomedical and population health projects with significant needs for secure research
data infrastructure, including HIPAA-compliant data management and storage. Unprecedented advances in
research computing and data capabilities are revolutionizing biomedical research and transforming discoveries
in these research domains. New computationally and data-driven research approaches such as artificial
intelligence, machine learning, omics, data mining and analytics, as well as computationally based simulations
and modeling are enabling bold new directions in biomedical research and drawing in entirely new biomedical
investigators whose studies are increasingly computationally based. Critical research data needs at UK reside
in prominent NIH-supported centers, including the Markey Cancer Center, the Alzheimer’s Disease Research
Center within the Sanders-Brown Center on Aging, and the Center on Drug and Alcohol Research, as well as
within a wide array of individual NIH-funded researchers. Burgeoning needs have placed critical demands on
the EDC to accommodate increased numbers of users, greater amounts of high-speed data storage, and
greater demand for high performance computing infrastructure. The proposed facilities expansion will expand
the 352 sq. ft. EDC, UK’s only HIPAA-secure data center (HITRUST Certification) by merging two vacant
adjacent rooms to create a secure 1,155 sq. ft. data center and ADA-compliant entry corridor and provide
requisite cooling, electrical distribution, and communication infrastructure to support the purchase and
installation of 28 additional racks of high-density, high-performance computing equipment through university
resources. The goal of the proposed 1,231 sq. ft. facilities renovation is to address a critical shortage of secure
biomedical research data center space at UK by more than tripling EDC capacity to accommodate
exponentially rising biomedical research volume and associated data infrastructure. The proposed expansion
is consistent with overarching UK priorities to support rapid advances in clinical and translation discovery
through enhanced capacity for secure, HIPAA-compliant data infrastructure and to continue to meet rapidly
expanding demand presented by NIH-funded researchers involved in data-intensive biomedical and population
health research. The proposed facilities expansion project is closely aligned with NIH priorities for data
management and sharing and embeds clear national impact by meeting those priorities.